Sjogren^s syndrome (Harris) - Centers for Inherited Disease Research Project

The funding supported genome-wide genotyping for approximately 1,500 participants from the Sjögren’s International Collaborative Clinical Alliance (SICCA) Registry.